Core B: Biostatistics/Bioinfomatics Core

PROJECT SUMMARY
The Program Project (P01) Biostatistics/Bioinformatics Core (BBC) will interact with all P01 investigators to
develop and apply appropriate analysis methods and designs to most efficiently achieve project goals. The Core
will work closely with investigators to ensure that research questions lead to experiments with quantifiable goals
and testable hypotheses. In addition, the Core will provide infrastructure and oversight for secure management
of all study data (whether from publically available resources or generated as part of this P01), working closely
with the Cores to facilitate accuracy and completeness of datasets for all projects and investigators. This will be
accomplished through the following aims: 1) To support all P01 investigators in the study design, conduct,
analysis, and reporting of results from all studies and 2) To provide secure and accessible database systems to
facilitate reliable and reproducible analysis of results from the experiments conducted by all P01 investigators.
The BBC serves as a centralized resource for all investigators involved in the P01, including all Projects and
other Cores. The Core will assist investigators with all facets of study design, analysis, and interpretation,
including appropriately powering experimental studies for sex differences. Established and innovative analytic
methods are available to promote scientific discovery. Core personnel will interact with P01 investigators in all
stages of research, from the formulation of the research questions, through experimental design, data
management, data analysis (including outcomes analysis), interpretation, writing scientific manuscripts, to
dissemination of results. The Core will also facilitate access to large datasets, whether from publically available
resources (TCGA and other publically available -omic data) or generated as part of this P01 through bulk and
single-cell sequencing in order to validate sex-specific molecular signatures and features identified in this P01.
The Core will assist all investigators with development, management and reliability of their project data and will
also integrate information across databases, such as incorporating clinical and experimental data with animal
and biospecimen data as provided by the Experimental Models Core. The Core will provide a natural foundation
for cross-pollination among the Projects and Cores. The BBC is integral to all components of the P01. We will
be performing data management, statistical/bioinformatics consultation and interpretation of results as well as
assisting with manuscripts/grants, throughout the entire grant period. Regular communication with the
Administrative Core will be maintained in order to ensure tracking and management of all Projects and Cores.
The BBC will work closely with the Experimental Models Core to assist with inventory of and tracking of use of
specimens (animal and human) and merging of clinical and experimental information on all specimens used for
all projects (including bulk and single-cell sequencing data). In addition, the Core will assist with assurance of
reproducible best practices for all Projects and Cores.
!

Public health relevance
PROJECT NARRATIVE The Program Project (P01) Biostatistics/Bioinformatics Core (BBC) will interact with all P01 investigators to develop and apply appropriate analysis methods and designs to achieve project goals. The Core will work closely with investigators to ensure that research questions lead to experiments with quantifiable goals and testable hypotheses. In addition, the Core will provide infrastructure and oversight for secure management of all study data (whether from publically available resources or generated as part of this P01), working closely with the Cores to facilitate completeness, accuracy and reproducibility of data for all projects and investigators